Maternal technology use during feeding and infant self-regulation and growth

PROJECT SUMMARY
The development of effective self-regulation skills is one of the most important achievements of early
childhood. During infancy, key interconnected domains of self-regulation include emotion (i.e., distress
regulation) and feeding (i.e., caloric intake regulation). An important foundation for infants’ developing
capacities for self-regulation is caregivers’ sensitive responsiveness to infant behavioral cues, especially during
feeding. However, given the ubiquity of portable technologies (e.g., smartphones), it is likely that many
caregivers are distracted by technology while feeding their infants, which may lower sensitive responsiveness
to infant cues. Surprisingly few studies have examined possible effects of technological distractors on the
quality and outcome of early feeding interactions. The primary aim of the proposed research is to examine
impacts of maternal technology use on early feeding interactions and change in these impacts across early
infancy. We also aim to test the hypothesis that greater habitual maternal technology use will predict poorer
infant emotion and intake regulation when infants are 6 and 12 months of age, greater socioemotional and
behavioral problems at 12 months, and greater infant weight gain between birth and 12 months. In addition, we
aim to describe levels of and changes in habitual maternal technology use from the prenatal and early
postpartum periods and examine predictors of habitual technology use patterns. We propose a 15-month
longitudinal study with nested within-subject experimental studies and bursts of daily passive sensing of device
use and time diaries. Pregnant women will be recruited and assessed during their 3rd trimester of pregnancy,
then mother-infant dyads will be assessed when infants are 2wk, 4mo, 6mo, 9mo, and 12mo of age. At 2wk
and 4mo, mothers and infants will be observed feeding under 3 counterbalanced within-subject experimental
feeding conditions: 1) Control, 2) TV Use, 3) Mobile Device Use. Videos of these feeding interactions will be
coded to obtain a comprehensive understanding of potential impacts of maternal technology use on maternal
attention, sensitivity to infant cues, and engagement of the infant, and on infant clarity of cues, attentional
responsiveness to the mother, and intake. Infant emotion and intake regulation, and related socioemotional
and behavioral problems, will be assessed via a combination of established behavioral protocols and validated
questionnaires. To describe patterns of habitual maternal technology use, we will integrate passive sensing
(via an app) of maternal technology use with time diaries; hypothesized predictors include maternal depressive
symptoms, stress, emotion regulation, feeding styles, and reflective functioning, and infant eating behaviors
and temperament. In sum, the proposed research is an innovative, multi-level examination of potential impacts
of maternal technology use on the quality and outcome of dyadic interactions during feeding. Findings from this
study will provide a foundation for further research aimed at understanding how to balance potential benefits
vs. drawbacks of technology use within family contexts.

Public health relevance
NARRATIVE Maternal sensitivity and contingent responsiveness to infant behavioral cues is an important contributor to infants’ developing capacities to self-regulate. During early infancy, feeding interactions comprise a significant portion of mother-infant dyadic interactions and high-quality feeding interactions provide both nutritive and socioemotional benefits; recent data from our laboratory suggest that, for many dyads, mothers’ sensitive responsiveness during feeding interactions is routinely impacted by the omnipresence of portable technology. The objective of the proposed research is to better understand the development and possible impacts of maternal technology use on infant feeding interactions, emotion and intake regulation, and sociobehavioral and growth outcomes.